Orexin agonists as novel obesity therapeutics

Overweight and obesity are common among Veterans served by the Veterans Health Administration (VHA).
Obesity and the chronic diseases associated with obesity place a tremendous burden on our healthcare system
and reduce quality of life for the general population as well as for Veterans. As our Veteran population ages over
the next decades, this burden will only increase. In addition to few effective pharmacotherapies for obesity
prevention, there are no effective therapies for long-term weight maintenance after weight loss in obese subjects.
Therapeutically targeting fundamental mechanisms that drive energy expenditure has a larger dividend in terms
of improving the health of the overweight Veteran population than would treating individual co-morbidities
associated with obesity. One of the possible mechanisms for the development of obesity is decreased availability
of the hypothalamic neuropeptide orexin. The orexin neuropeptide, produced in the lateral hypothalamus, are
key regulators of physiological functions, including energy homeostasis, sleep/wake stabilization and cognition.
A defective orexin system results in weight gain despite reduced food intake, and complete absence of orexin
neurons results in the sleep disorder narcolepsy, which is also characterized by weight gain, despite reduced
food intake. We and others have consistently demonstrated that orexin enhances physical activity and energy
expenditure, and improves sleep/wake patterns. Despite this demonstration that the orexin system can be
targeted for weight loss, it’s not feasible to peripherally administer the orexin peptide itself due to its lack of blood-
brain barrier permeability. Therefore, to achieve obesity therapies based on orexin, the development and testing
of small molecular weight orexin agonists is needed.
The overarching hypothesis of this proposal is that small molecular weight agonists for orexin will prevent
and reverse diet-induced obesity, through increasing energy expenditure and improving sleep/wake patterns.
The goals are to systematically test the efficacy of two small molecule orexin agonists in preventing and reversing
high-fat diet-induced obesity by enhancing energy expenditure and improving sleep/wake behavior. To this end,
we will expose mice to high-fat diet and use indirect calorimetry in conjunction with wireless radio-telemetric
sleep/wake behavioral analyses, to determine if activation of orexin receptors using peripheral novel small
molecule orexin agonists prevents and/or reverses obesity, and improves behavioral sleep/wake patterns. The
immediate goal is to generate sufficient preclinical data to support use of small molecular-weight orexin agonists
to prevent adverse body weight outcomes associated with exposure to obesogenic environments. The long-term
goal is to enable research and development of orexin agonists as therapies for obesity and associated
comorbidities commonly observed in the Veteran population.

Public health relevance
Obesity and its associated comorbidities reduces healthspan and quality of life, including that of Veterans. Easy access to obesogenic diets drives weight gain, metabolic disorders and sleep disturbances. Orexin is a brain compound that increases calorie burning while stabilizing sleep/wake states, and it prevents weight gain during overfeeding in rodents. We would like to develop orexin-based anti-obesity therapies for humans, but orexin itself does not cross the blood-brain barrier, which is needed to achieve the anti-obesity affects. To this end, we have developed two novel compounds (orexin agonists) that mimic the effects of orexin, but which can cross the blood-brain barrier, making them promising candidates for use in human obesity. In this application we will test these two novel small molecular weight orexin agonists in mice, to determine their effectiveness as anti-obesity agents and in improving sleep/wake patterns. The overall goal is to provide preclinical data on these agents for use in future studies, to help address obesity in the Veteran population.